Effects of the Luminal Microenvironment on Pro-Carcinogenic Microflora of the Esophagus

This application is to provide an integrated career development experience to Dr. Ikenna Okereke within the translational team-based training program of the UTMB CTSA. Guided by an Individual Development Plan (IDP), the team-based training experience has been highly effective in improving the success and satisfaction of translational research scholars. To this end, Dr. Okereke will participate in a multidisciplinary translational team that will provide inter-professional research experience, focused training, access to role models and mentoring experiences (both mentor-protégé, and peer-peer types). This project will help to promote UTMB CTSA’s strategic goal to address health disparities in underserved and lower socioeconomic populations. His focus on the stratification of risk of patients with Barrett’s esophagus, which is a relatively prevalent condition in this country, will help to determine which patients with Barrett’s esophagus are at increased risk for development of esophageal cancer. Unfortunately, the current trend in this country is that patients in underserved and lower socioeconomic regions are more likely to be diagnosed with esophageal cancer at an advanced stage and with worse survival. Dr. Okereke’s project addresses that disparity by attempting to find a method to identify high-risk patients which can be applied broadly and utilized by a large part of our population. His focus on the risk stratification of patients with Barrett’s esophagus furthers the UTMB CTSA’s goals to expand clinical research in special populations (lower socioeconomic). Finally, Dr. Okereke’s translational team will further advance the collaborative effort between the UTMB CTSA and the CCTS, two founding members of the TRCC. In this way, this project will enhance and advance further interactions between these collaborating regional institutions.

Public health relevance
PROJECT NARRATIVE Esophageal cancer is the one of the most common causes of cancer-related deaths in this country, and is one of the few solid-organ cancers which has been increasing in incidence in the last 20 years. This project will help to promote The University of Texas Medical Branch at Galveston's CTSA strategic goal to address health disparities in underserved and lower socioeconomic populations. Specifically, the focus on the stratification of risk of patients with Barrett's esophagus, which is a relatively prevalent condition in this country, will help to determine which patients with Barrett's esophagus are at increased risk for development of esophageal cancer.